Dissecting the Role of Src Family Kinases in Breast Cancer Brain Metastasis

Project Summary/Abstract Title: Dissecting the Role of Src Family Kinases in Breast Cancer Brain Metastasis PI: Siyuan Zhang, M.D., Ph.D., The University of Texas M.D. Anderson Cancer Center I received my M.D. in 1998 from Peking University Health Science Center and a Ph.D. degree in Cancer Biology from the National University of Singapore in 2005. My Ph.D. training was focused on deciphering the molecular mechanisms of the anti-cancer activity of parthenolide - an active component in natural product feverfew. I was the first author in 7 of the 9 papers I published during Ph.D. training. I joined Dr. Dihua Yu's group at The University of Texas M.D. Anderson Cancer (MDACC) in 2007 to pursue my goal of making discoveries of clinical impact. My research elucidated a key mechanism of trastuzumab resistance and led to the development of a novel clinically-translatable combinatorial regimen for trastuzumab-resistant patients. Meanwhile, I am also investigating the role of PTEN loss in breast cancer brain metastasis. My current research goal is to study the role of certain genetic alterations in breast cancer brain metastasis and establish myself as an independent researcher through K99 funding. My long-term research goal will be focused on two important areas: (1) Basic research, investigate the mechanisms of metastasis by focusing on the contribution of the pre-metastatic microenvironment; and (2) Translational research, based on basic research findings to identify, design and pre-clinically test novel therapeutic regimens for treatment of cancer metastasis. To achieve my short-term and long-term career goals, during the K99 mentored phase of this grant, I will receive comprehensive training based in an unmatched training environment for cancer research- MDACC. I will cooperate with my mentors and actively participate in formal courses, workshops and seminars to broaden my knowledge and skills, particularly in genetically-engineered mouse models. The career development training in scientific writing, research ethics, lab management and leadership skills will further facilitate my transition as an independent scientist. My research plan is focused on the role of Src family kinases (SFK) in breast cancer brain metastasis. Among 1.3 million women diagnosed with breast cancer every year worldwide, about 10- 16% will develop brain metastases. Even with most advanced clinical care, the overall survival for brain metastasis patients is less than 14 months from diagnosis. At present, no effective treatment exists for patients with refractory metastatic breast cancer brain metastasis. Therefore, novel and effective therapeutic approaches are urgently needed for this population. Unfortunately, developing effective therapeutics for brain metastasis is largely hampered by a shortage of in-depth understanding of the basic mechanisms of brain metastasis. Our preliminary studies suggest that Src family kinase c-Src plays an important role in both metastatic tumor cells and brain metastasis microenvironments. The major goal of the proposed project is to use innovative approaches to dissect the role of Src family kinases in the brain metastasis process and develop novel therapies for breast cancer brain metastasis patients. We propose three comprehensive aims: 1) Aim 1 (K99 phase): Determine the role of tumor SFK activation in breast cancer brain metastasis. 2) Aim 2 (R00 Phase): Determine the impact of SFK activation in the brain pre-metastatic microenvironment on breast cancer brain metastasis. 3) Aim 3 (R00 Phase): Investigate the pre-clinical efficacy of novel SFK-targeting therapeutic regimens in the treatment of breast cancer brain metastasis. Success of the project will promote my career transition from my position as a mentored postdoctoral fellow to becoming an independent scientist with my own research direction. More importantly, novel insights from this study into the mechanisms of breast cancer brain metastasis will guide the development of novel clinically-translatable regimens that offer fresh opportunities for the treatment of a devastatingly intractable disease.

Public health relevance
Project Narrative Title: Dissecting the Role of Src Family Kinases in Breast Cancer Brain Metastasis PI: Siyuan Zhang, M.D., Ph.D., University of Texas M.D. Anderson Cancer Center For breast cancer patients, no effective treatments exist for patients with refractory breast cancer brain metastasis. Using innovative approaches, the proposed project aims to decipher mechanisms of brain metastasis by focusing on both metastatic breast cancer cells and the brain metastasis microenvironment. Ultimately, we will design and perform pre-clinical testing on novel combinatorial therapies for breast cancer brain metastasis that can be smoothly transitioned into the clinic. __SpecificAimsTextDelimiter__ Title: Dissecting the Role of Src Family Kinases in Breast Cancer Brain Metastasis PI: Siyuan Zhang, M.D., Ph.D., The University of Texas M.D. Anderson Cancer Center Among the 1.3 million women diagnosed with breast cancer every year worldwide, about 10-16% will develop brain metastases. The median survival of patients with brain metastases is less than one year. Initial treatment options include steroids, cranial radiotherapy, and surgical resection in selected patients. However, the majority of patients relapse within a year under the current clinical care. This represents one of the most challenging problems in the cancer field: beside surgery and radiotherapy, there is no effective drug treatment for patients with refractory metastatic breast cancer to the brain. Therefore, novel and effective therapeutic approaches are urgently needed for this population. Design of effective treatment relies on our basic understanding of the disease. Unfortunately, we lack an in-depth understanding of the basic mechanisms of the brain metastasis process and a comprehensive insight of both metastatic tumor cells and their brain metastatic microenvironment. This project will be focused on one of the critical regulators of metastasis. The major goal of this project is to explore the intriguing role of Src family kinases (SFK) in regulating both metastatic tumor cells and brain microenvironment during the brain metastasis process. We will develop and pre-clinically test novel Src inhibitor-containing therapeutic regimens for brain metastasis. Retrospective microarray analysis indicated that basal-like and HER2-overexpressing (HER2+) breast cancer patients have a significantly higher incidence of developing brain metastasis. SFK activation is one of the key events downstream of HER2. Our preliminary analyses of SFK activity in brain-seeking cell lines and clinical brain metastasis tumors revealed that SFK activity is up-regulated in brain metastasis. In addition, basal-like breast cancer cells are especially sensitive to SFK inhibitor treatment. In our preliminary study, hyper-activation of SFK in a basal-like cell line led to a significantly higher incidence of brain metastasis. This evidence suggested a potential role of Src in brain metastasis from basal-like and HER2+ breast cancer. In addition to the critical role of SFK in metastatic tumor cells, SFK can also modulate the metastatic microenvironments. SFK activation in the metastatic microenvironment up-regulates vascular endothelial growth factor (VEGF) and promotes vascular permeability (VP). Disruption of endothelial cell tight junctions facilitates the extravasation of metastatic tumor cells into the organ parenchyma. In the brain, Src knockout suppresses the infiltration of existing glioblastoma to other parts of the brain parenchyma. Our preliminary data also suggested that paracrine factors from reactive astrocytes promote tumor cell proliferation. This evidence suggests an intriguing role of Src in maintaining the function of astrocytes, critical players in blood brain barrier integrity, and a potential role of the local brain microenvironment for brain metastasis. Thus, we hypothesize that 1) activation of SFK plays a critical role in both promoting metastatic properties of tumor cells and modulating a favorable metastatic brain microenvironment; 2) Targeting SFK in combination with current therapy for breast cancer brain metastasis may bring significantly better pre-clinical efficacy. Here we propose three comprehensive aims: Aim 1 (K99 phase): Determine the role of tumor SFK activation in breast cancer brain metastases. In this Aim, we will use human breast cancer cell lines and experimental metastasis models to study 1) the role of SFK activation in breast cancer brain metastasis in vitro and in vivo; 2) the mechanisms of SFK activation in promoting breast cancer brain metastasis. Aim 2 (R00 Phase): Determine the impact of SFK activation in brain pre-metastatic micro- environment on breast cancer brain metastases. In this Aim, we will use human breast cancer brain-seeking cell lines, experimentally-induced metastasis methodology and Src knockout mice to study 1) the role of Src knockout in the brain microenvironment on breast cancer brain metastasis using an immunodeficient mouse model; 2) the role of Src knockout in the brain microenvironment on breast cancer brain metastasis using a congenic mouse model. Aim 3 (R00 Phase): Investigate the pre-clinical efficacy of novel SFK-targeting therapeutic regimens in the treatment of breast cancer brain metastases In this Aim, we will use human breast cancer brain-seeking cell lines and experimental metastasis models to study 1) the effects of a Src inhibitor alone on breast cancer brain metastases in vitro and in vivo; 2) the molecular mechanisms of Src inhibitor-mediated inhibition of brain metastasis; 3) the preclinical efficacy of SFK inhibitor plus lapatinib combinatorial therapy in the treatment of breast cancer brain metastasis in vitro and in vivo. We expect the success of the project will lead to novel insights into brain metastatic tumor cells as well as their metastatic environments. Ultimately, we expect our research findings will lead to clinically-translatable regimens for better treatments for breast cancer brain metastasis and long-term improved patient care.